mHealth to Enhance & Sustain Drug Use Reduction of the QUIT BI in Primary Care

PROJECT SUMMARY. The QUIT-Mobile study proposes to use mobile phone self-monitoring and feedback
to enhance and sustain over 12-months the impacts of the Quit Using Drugs Intervention Trial (QUIT), an ef-
fective screening and brief intervention (SBI) previously successful in reducing risky drug use (i.e., moderate
use) in low-income, diverse patients over a 3-month follow up. We propose to conduct the QUIT-Mobile study
for primary care patients who receive care in 8 clinics of federally qualified health centers (FQHC) in Southern
California over 12-months follow up, comparing to QUIT and Usual Care (UC). The proposed study is an Effec-
tiveness-Implementation Hybrid Type 1 design consisting of a single-blind, 3-arm, RCT with adult, mostly La-
tino FQHC primary care patients with risky drug use (ASSIST score 4-26), randomized to 3 conditions
(n=320/arm, n=960 total): 1) QUIT-Mobile; 2) standard QUIT; 3) Usual Care. Qualitative data on implementa-
tion facilitators and barriers will inform future scale-up and sustainability, in addition to cost data and cost-effec-
tiveness analysis. The aims are to examine effectiveness in reducing risky drug use and cost-effectiveness
comparing the three arms over 3-, 6- and 12-months. Drug use measures include urine drug tests, and timeline
follow-back self-reports for past 7-days and past 30-days (risky drug users have sporadic drug use patterns
requiring longer self-report recalls for drug use that urine screens may not detect). The 3-arm study enables
testing of the independent and synergistic effects of QUIT-Mobile compared to QUIT and both to Usual Care,
acknowledging that mHealth components alone may not be effective outside of a clinical/coaching relationship.
The 12-month timeline reflects anticipated scale-up scenarios of annual primary care visits when screening
and brief intervention would be repeated routinely. QUIT contains 3 components: 1) patient screening with the
WHO ASSIST, 2) brief clinician advice (<4 minutes) including opioid overdose prevention education, and 3) 2-
and 6-week telephone drug-use health coaching sessions utilizing motivational interviewing and cognitive be-
havioral techniques, delivered by paraprofessional health coaches. QUIT-Mobile proposes to test the addition
of mobile phone self-monitoring, feedback, and coach monitoring dashboard to enhance and sustain QUIT's
drug use reductions using mobile app, text-messaging (SMS), or interactive voice response (IVR) to allow par-
ticipation by with varying technological preferences. This study does not test which technology platform is more
effective, but rather, the effectiveness of the intervention functions (i.e., self-monitoring, automated feedback,
coach monitoring) that are delivered via patients' preferred technologies. This study is novel and timely in inte-
grating massively scalable mobile phone tools into an effective primary care BI to prevent substance use disor-
der (SUD) in FQHC patients delivered by paraprofessionals. QUIT-Mobile is responsive to the National Opioid
Crisis, and the US Mental Health Parity Act and National Academy of Medicine recommendations to integrate
behavioral health SBIs into primary care settings to prevent higher level SUD requiring specialty treatment.

Public health relevance
PROJECT RELEVANCE TO PUBLIC HEALTH Only recently has a screening and brief intervention in low-income primary care settings been shown to reduce patients' illicit drug use over 3-months. Good as this finding is, the next challenge is to sustain patients' drug use reductions over 12-months to coincide with routine annual primary care visits for rescreening. We propose adding mHealth tools to enhance and sustain drug use reductions in an effective SBI to reduce drug use and prevent addiction.